Identifying the Molecular Function of the Y-linked Mouse Zinc Finger Proteins ZFY1 and ZFY2

Project Summary
The mouse zinc finger proteins ZFY1 and ZFY2 are essential for male fertility. Although human ZFY’s reproductive role has
not yet been determined, the Y-derived Zfy transgenes improve spermatogenesis when added to mouse models with
limited Y chromosome contribution. Specifically, Zfy (1) reinstates quality control checkpoints during the pachytene stage
and metaphase I of meiosis, (2) promotes the second meiotic division and production of haploid round spermatid, and (3)
improves spermiogenesis and assisted reproduction outcome. Nakasuji et al. and the Ward Lab recently produced Zfy1/2
double knock-out (DKO) mice, with both groups observing a complete loss of fertility and severe defects in
spermatogenesis. The mechanism by which the homologues contribute to male fertility remains unknown but based on
its predicted protein sequence and in vitro assays in human cultured cells ZFY is widely believed to be a transcription
factor. Transcriptome and proteome analyses of germ cells from Zfy1/2 DKO mice will help identify which genes are
regulated by ZFY1 and ZFY2, and the biochemical function of both proteins can be determined by antibody-based assays
such as immunoprecipitation (IP) and chromatin immunoprecipitation (ChIP). The proposed project will investigate the
molecular function of ZFY, with the hypothesis that ZFY1 and ZFY2 contribute to spermatogenesis and male fertility by
regulating the expression of a cascade of reproduction-related genes. This hypothesis will be tested in two specific aims.
In Specific Aim 1, we will perform transcriptome and proteome analyses of primary spermatocytes (ps), secondary
spermatocytes (ss), and round spermatid (rs) from Zfy1/2 DKO males to determine which genes are dysregulated in the
absence of ZFY. This will involve isolating Zfy1/2 DKO germ cells via fluorescence-activated cell sorting (FACS), extracting
RNA and protein from each cell type, and then performing RNA-seq and mass spectrometry (MS). Potential downstream
candidates of ZFY1 and ZFY2 will then be identified from the genes dysregulated in DKO mice. In Specific Aim 2, antibody-
based assays will be performed to discover the biochemical function of ZFY1 and ZFY2 in the mouse testis. This will require
first generating a method to detect ZFY1 and ZFY2 proteins. Thus, in Aim 2.1, zygotes will be targeted with CRISPR/Cas9
technology to create knock-in (KI) mouse models, independently for each homologue, in which targeted ZFY will have a C-
terminal HA tag (XYZfy1-HA and XYZfy2-HA). In Aim 2.2, we will confirm that we can specifically recognize ZFY1 and ZFY2
proteins, as well as any potential binding partners, with immunoprecipitation and liquid chromatography followed by
tandem mass spectrometry (IP/LC/MS). Finally, in Aim 2.3, purified spermatogenic cells from the KI mice will be used for
ChIP-PCR to determine whether ZFY1 and ZFY2 regulate expression of selected downstream candidates identified in
Specific Aim 1. Additionally, ChIP-seq will be done to identify ZFY1 and ZFY2 targets genome-wide. The proposed project
will advance understanding of the function of two known fertility factors, ZFY1 and ZFY2, in mice. It may lead to
identification of new fertility genes among targets of ZFY homologues, which could in turn inform our knowledge on the
homologous human ZFY isoform.

Public health relevance
Project Narrative This project seeks to advance understanding of the origin of male infertility. The mouse zinc finger proteins ZFY1 and ZFY2 are putative transcription factors that are required for proper spermatogenesis, but their biochemical function is unknown. To address this gap in knowledge we will determine which reproduction-related genes are regulated by ZFY and the mechanism by which this regulation occurs.